DATA COORDINATING CENTER FOR ADDITIONAL FETAL 3D STUDY MEASUREMENTS

Using state-of-the-art viewpoint and 4D view GE Healthcare technology, the data from an existing bank of 2D and 3D ultrasound images of singleton and twin gestations collected from pregnant women who participated in the NICHD Fetal Growth Studies shall be entered into a web based data management system.